Blood-brain barrier disruption with implantable ultrasound to enhance paclitaxel delivery: A Phase 1-2 clinical trial in recurrent glioblastoma

ABSTRACT/SUMMARY
Drug therapy in glioblastoma (GBM) almost invariably fails in patients despite having shown efficacy in preclinical
models, or in the treatment of other solid tumors. One important reason for failure is insufficient drug penetration
across the blood-brain barrier (BBB). Pulsed-ultrasound (US) with concomitant injection of intravenous
microbubbles transiently disrupts the BBB, enhancing delivery of drugs to the brain. In patients this requires
ultrasound waves to bypass the thick human skull. Here we use an US device implanted into a skull window that
has been successfully tested in Phase 1 clinical trials. Prior studies have shown BBB disruption, and prolonged
progression-free survival of recurrent GBM patients treated with US-mediated BBB and carboplatin
chemotherapy. Yet, the true effect of US-based BBB disruption on drug concentrations in peri-tumoral human
brain remains unknown, while achieving adequate drug concentrations in the peri-tumoral tissue is key for
targeting infiltrating GBM cells beyond surgical margins. Paclitaxel (PTX) is exquisitely potent against GBM in
preclinical models. Prior clinical studies exploring PTX’s role in GBM showed that in the peri-tumoral brain the
drug was undetectable. Moreover, Cremophor™, the solvent used in conventional PTX formulations has
neurotoxicity. Thus, whereas PTX remains one of the most potent drugs against GBM, it cannot be exploited
due to poor BBB penetration and vehicle-related toxicity. Our recent work demonstrates that a novel FDA-
approved formulation of albumin-bound PTX (Abraxane®, ABX) that does NOT contain Cremophor™, is well
tolerated and exhibits better brain and other tissue penetration than conventional PTX. US-based BBB disruption
increased PTX brain tissue concentrations 5-fold. Our premise is that PTX will be effective against human GBM
if sufficient tumor and brain concentrations are achieved. We hypothesize that US-based delivery of ABX will be
tolerated, substantially increase PTX concentrations in peri-tumoral brain, and provide a survival benefit for
recurrent GBM patients. To investigate this, we will conduct a Phase I/II trial of US-enhanced delivery of ABX for
recurrent GBM patients. We will determine safety and MTD, and evaluate for early-signs of efficacy (Aim 1). We
will use a 2nd generation implantable US device that covers a 9-fold broader sonication volume than the initial
prototypes, and we use ABX, a drug that is far more potent in all preclinical models than the previously studied
carboplatin. We will biopsy and measure PTX concentrations in various zones of the tumor and infiltrated peri-
tumoral tissue following US-based BBB disruption (Aim 2). Repeat MRI will allow for determination whether the
field of BBB disruption is associated with local disease control and prevents progression (Aim 3). These studies
will 1) determine the safety of US-based BBB disruption with concomitant ABX infusion, 2) quantify the effect of
BBB disruption on PTX brain concentrations, and 3) provide clinical and radiographic assessment of efficacy.
!

Public health relevance
NARRATIVE The blood-brain barrier (BBB) is major obstacle to medical therapy of infiltrative glioma. Here we test an approach that allows for repeated and reversible BBB disruption, thus allowing systemic agents to penetrate the brain and tumor tissue in high concentrations. Our clinical trial will directly investigate the efficacy of this approach for delivery of paclitaxel, one of the most potent chemotherapeutics for this disease, and test the ability of this technology to actually increase the concentration of drugs in the human brain, a key question for drug delivery for brain cancer.